Structure, Turnover and Safeguard of Mitochondria

Summary
Mitochondria are essential organelles that control the life and death of cells. Mitochondria are highly
dynamic: They grow, divide, and fuse, and when they eventually become damaged, undergo degradation
Mitochondrial division is mediated by a dynamin-related GTPase, DRP1, while fusion is mediated by two
dynamin-related GTPases, OPA1 and mitofusin. These GTPases are mutated in human diseases, including
neurodevelopmental disorder, Charcot-Marie-Tooth neuropathy, and optic atrophy. Altered activities of these
proteins have also been linked to metabolic syndrome, cardiovascular disease, and age-related
neurodegeneration. My laboratory’s goal is to decipher the molecular mechanisms that control mitochondrial
structure and translate the fundamental biology to disease interventions. In the past two decades, we have
identified and characterized the three essential GTPases in the core reactions of membrane fusion and
division. The roles of mitochondrial dynamics are ever-expanding, and now include size control of
mitochondria, their distribution and turnover, and differentiation of neurons, cardiomyocytes, stem cells, and
immune cells. Most recently, it became evident that the mechanisms of mitochondrial division and fusion are
much more complex than initially imagined, involving inter-organelle interactions and a feedback response that
monitors and tunes their balance. The emerging new biology is transforming the field of mitochondrial structure
and dynamics. In the next 5 years, we will address the important questions raised by this intellectual evolution.
First, to our surprise, we found that DRP1 shapes the endoplasmic reticulum (ER) into tubules that form
contract sites with mitochondria. DRP1-produced ER-mitochondria contact sites strongly promote
mitochondrial division. We will investigate how DRP1 creates ER-mitochondria contact sites that
specifically function in mitochondrial division, associates with the ER, and deforms the ER membrane.
Second, we discovered a physiological pathway of mitochondrial turnover via DRP1-controlled, Parkin/PINK1-
independent mitophagy in mice. This pathway’s most upstream event is to recognize and mark damaged
mitochondria by ubiquitination of mitochondrial proteins. Our initial experiments suggested that ubiquitination
occurs in two phases – reversible initiation and committed amplification. We will determine what
ubiquitinates mitochondria in each phase, and how the ubiquitin ligase complexes recognize and label
damaged mitochondria in vivo. Third, we found the first example of a stress response (MitoSafe) that senses
and adjusts the mitochondrial structure by controlling the balance between fusion and division. We will
explore the molecular basis of MitoSafe and its physiological roles in mice. The MIRA grant will enable
us to discover the new logics of mitochondrial structure and its physiological role and regulation in vivo.

Public health relevance
Project Narrative Defects in mitochondria structure and function have been linked to human health problems including metabolic syndrome, cardiovascular diseases, and neurodegeneration. This proposal aims to determine fundamental mechanisms that control structure, turnover, and safeguarding of mitochondria. The successful completion of this work will provide major insights into the pathogenesis and treatment of human disease.